Mechanisms of Lipid A Modification Impacting Antimicrobial Resistance

Mechanisms of Lipid A Modification Impacting Antimicrobial Resistance
Marcelo Sousa
University of Colorado Boulder
Project Summary
Human Cationic AntiMicrobial Peptides (CAMPs) represent a conserved branch of the innate immune system.
CAMPs constitute a first line of defense against bacterial colonization that is particularly important in exposed
tissues and surfaces such as the skin, eyes, airways and lungs. Furthermore, CAMP antibiotics such as colistin
and related polymyxins are a class of essential drugs in clinical use to treat recalcitrant infection with multidrug
resistant Gram-negative bacteria. These include the “urgent threat” pathogens carbapenem resistant
Acinetobacter baumannii, Carbapenem Resistant Enterobacteriaceae (CRE) as well as “serious threat”
pathogens such as Multidrug Resistant (MDR) Pseudomonas aeruginosa. However, these and other Gram-
negative pathogens have evolved mechanisms to modify lipid A in the outer membrane of bacteria (the
CAMP/colistin target) most commonly with 4-amino-arabinose (Ara4N), which result in resistance to the
bactericidal activity of CAMPs and colistin. This is a significant clinical problem with pathogens that produce
persistent infections with high mortality rates. Therefore, development of inhibitors of the Ara4N-Lipid A
modification pathway is a desirable therapeutic strategy that would result in potentiators of colistin against deadly
multidrug resistant pathogens. The enzymes responsible for the biosynthesis of Ara4N-Lipid A are clustered in
the ArnBCADTEF operon. Mutation of any of these genes abolishes Ara4N addition to Lipid A and colistin
resistance. Therefore, these proteins are validated targets for drug development to abolish colistin resistance.
However, the biochemical characterization of several of these targets is either lacking or incomplete.
Furthermore, in vitro activity assays are either currently unavailable or inadequate for quantitative evaluation of
putative inhibitors. This knowledge gap impairs development of colistin adjuvants that could improve the efficacy
of this life-saving antibiotic. We will close this gap with an integrated, collaborative research program to
structurally and functionally characterize three proteins directly responsible for CAMP/colistin resistance, screen
for probes to define inhibitory strategies, and develop a platform to quantitative test impact of target activity in
vitro, in bacteria and in a tissue culture Salmonella infection model. Successful completion of this multidisciplinary
program will result in new insights into the mechanisms of lipid A modification leading to CAMP/colistin resistance
and provide fully characterized targets with validated assays and inhibitory probes. This represents a superb
platform for future development of adjuvant drugs that augment the efficacy of colistin in treatment of infections
with multidrug resistant bacteria.

Public health relevance
Mechanisms of Lipid A Modification Impacting Antimicrobial Resistance Marcelo Sousa University of Colorado Boulder Narrative: Colistin and other polymyxins belong to a class of last resort antibiotics for the treatment of multidrug resistant pathogens. However, Gram-negative bacteria have evolved resistance to this class of antibiotics by chemically modifying their envelope. This proposal is focused on understanding the molecular basis of the resistance mechanism, as a necessary platform to develop inhibitors of resistance that would render the bacteria sensitive to essential “last-resort” antibiotics.